NIH: Spatial Models of Intrahepatic Hepatitis Virus Propagation in Humans

Summary
Significance: Hepatitis B virus (HBV) infects ~260 million people worldwide and is the leading cause of liver
disease and hepatocellular carcinoma (HCC) in the world. Despite an effective vaccine for infection prevention,
chronic hepatitis B virus infection (CHB) is difficult to cure once established. The viral genetic material enters
the infected cell's nucleus generating a stable covalently closed-circular DNA (cccDNA) molecule or a linear
form that integrates into the host cell's chromosome (iDNA). Existing treatments have little effect on cccDNA
and as a result have poor success rates. Treatment interruption often leads to rebound of HBV DNA and
recurrent hepatitis. In addition, even with treatment, liver disease in CHB often progresses to decompensated
cirrhosis requiring liver transplantation. This process is exacerbated by several viral co-infections, such as with
HIV or hepatitis C virus (HCV). Thus, improved therapeutics for CHB cure are required.
Innovation: Our proposal is innovative in three aspects. i) access to precious and unique samples of liver
tissue; ii) using state-of-the-art experimental techniques for single cell analyses and contemporaneous blood
biomarkers; iii) development of new multi-scale models of HBV infection informed by our rich data sets, which
are designed for clinical usefulness.
Approach: HBV has a complex lifecycle comprising intracellular and extracellular phases. Our team has
developed tools to interrogate the intracellular phase of HBV at the single-hepatocyte level. We have made
preliminary observations of HBV in single cells but have only recently begun to link the intracellular and
extracellular phases of HBV. Thus, we are poised to uncover key links in HBV biology between blood and liver.
Using an integrated approach, we propose developing models of HBV that characterize replication in the
organism uniting our understanding of intracellular and extracellular phases of the virus. Our specific aims are:
i) To develop integrated models of intracellular and extracellular HBV replication, measuring and
modeling a comprehensive set of HBV-related biomarkers in the blood and at the single-cell level in the liver, in
untreated and treated CHB; and ii) To develop models of HBV spatial spread and persistence in the liver,
using single-cell viral sequencing of HBV to make spatial linkages between genetically related HBV variants in
the liver. These data and models will allow inferences about local versus non-local HBV spread. Specifically,
we will test if clonal proliferation of HBV infected hepatocytes may contribute to continued persistence of
infected cells, which has important implications not only for cure research but also for HCC oncogenesis.
Impact: As multiple novel compounds for HBV treatment are in development, the timely insights generated in
this proposal will fill gaps in our understanding of HBV replication and pathogenesis. Previous efforts by us and
others in modeling HCV and HIV were important in the development of successful therapies for those
infections. We expect the new data and models generated here to have the same impact in advancing HBV
therapy.

Public health relevance
Hepatitis B virus (HBV) infects over 260 million people worldwide, causes significant pathology, and is one of the leading causes of liver transplant in the USA. This project joins clinicians and modelers to develop new insights into chronic HBV infection in humans by building multiscale models of disease propagation from the single cell at the intrahepatic (liver) level to the whole organism.